Predicting the Toxicity of PAHs

PROJECT SUMMARY – TANGUAY PROJECT
Polycyclic aromatic hydrocarbons (PAHs) are ubiquitous contaminants at Superfund sites. The physical
proximity of millions of people to PAH contamination challenges regulatory agencies to provide accurate risk
assessments in order to protect public health. The potency for a small subset of individual parent PAHs to
produce cancer is fairly well understood, but the hazard posed by their numerous environmental derivatives
remains unclear. Furthermore, humans always suffer exposure to PAHs in the form of complex mixtures rather
than as individual parent PAHs. Persistent alkylated PAHs (a-PAHs) are the most abundant at Superfund sites,
but the scientific community has collected little or no toxicity for most alkylated PAHs.
In addition to cancer, developmental exposure to PAHs may carry high risk. Recent epidemiological data
associate PAH exposures with birth defects, neurobehavioral deficits, and heart disease. During the past funding
cycle, we determined that the toxicity of transformed PAHs can exceed that of the parent compounds. Risk
assessors desperately need relevant in vivo data to develop comprehensive models for predictive toxicity.
The Tanguay Project will link biological responses to PAH structures, uptake, and diagnostic gene expression
pathways with their high-throughput zebrafish testing platform and thereby provide rapid feedback to SRP
interested parties responsible for risk assessment and remediation. This approach, in one integrated experiment,
interrogates all aspects of development and the molecular pathways that underlie it. Through cross-center
interactions, we have developed an effective framework to convey this high-impact work to interested parties
and to collaborate with populations to reduce their risk.
Our overarching hypothesis is that we can learn to predict the toxicity of PAH mixtures based on the structural
characteristics, bioactivity profiles, and pathway targets of their PAH components. We will test this hypothesis
in four Specific Aims: 1) Determine how the developmental impacts of PAH exposure depend on the composition
of PAH mixtures, the chemical structures of environmentally transformed PAHs, and the presence of AHR
signaling. 2) Develop diagnostic gene expression pathways for classes of PAHs, determine how those pathways
vary as a function of dose, and associate those pathways with specific adverse effects. 3) Discover the external
stressors that impact the susceptibility to PAHs. 4) Determine the carcinogenicity of PAHs by conducting long-
term zebrafish studies.

Public health relevance
PROJECT NARRATIVE – TANGUAY PROJECT Our Center has begun to understand the overwhelming diversity of PAHs at Superfund sites, including understudied alkylated forms. This project will evaluate the toxicity and carcinogenicity of PAHs and their mixtures. Our goal is to help the research and regulatory communities predict the hazards and risks of real-world PAH mixtures.